Extracellular Vesicle treatment and age-related neuropathology in non-human primates

ABSTRACT
In our previous grant (R01AG068168) we demonstrated the efficacy of mesenchymal stromal cell (MSC)-derived
extracellular vesicles (EVs) from young monkeys to slow or reverse age-related cognitive decline in aging
rhesus monkeys. Compared to controls, EV-treated monkeys showed a higher level of performance on a spatial
working memory task, which was correlated with increased Aβ42 protein concentration in the CSF, possibly
due to enhanced clearance. EV-mediated improved spatial working memory was also correlated with enhanced
white matter integrity, functional connectivity in vivo and greater excitability of pyramidal neurons in prefrontal
cortex, pointing to compensatory mechanisms that may promote plasticity during aging. In addition, extensive
proteomic profiling of the contents of our monkey EVs identified the enrichment of proteins involved in several
neuritogenic and synaptogenic processes that provide mechanistic insight on the ability of the EVs to ameliorate
age-related changes in the brain. Furthermore, our in vitro studies showed that EVs mitigate age- and AD-related
neurodegenerative changes in human-derived cortical organoids (COs). Together these findings demonstrate
the significant therapeutic efficacy of MSC-EVs in aging. However, recent evidence has demonstrated sex
differences in the cargo and gene expression in EVs. Recent transcriptomic studies have demonstrated that
EVs from male donors express a greater variety and abundance of RNAs than those from female donors.6
Further, differentially expressed genes (DEG) in male EVs were associated with intracellular signaling and
vesicle transport, whereas DEGs in female EVs were associated with extracellular matrix organization and
signal transmission. These outcomes suggest that male and female EVs may support different biological,
repair and immunomodulatory processes and therefore may have different effects on the aged brain.6 In the
previous grant, our studies used EVs from both male and female donors. However, our most recent data
showed a positive effect of female EVs on cognition, white matter integrity and neuropathological debris
clearance. In this renewal, we now propose to conduct an in-depth analysis of the mechanistic action and
efficacy of EVs from MSCs from both male and female donors, to determine sex differences in the ability of
EVs to ameliorate age-related impairments in cognition, facilitate clearance of neurodegenerative debris
and reduce inflammation in monkeys and human-derived COs. Based on our data and evidence from the
literature we hypothesize that EVs derived from female MSCs will have more efficacious therapeutic benefits,
including increased clearance of age-related neurodegenerative debris that will correlate with white matter
integrity, neuronal plasticity and improved cognitive function.

Public health relevance
Narrative In our current R01(AG068168), we demonstrated the efficacy of mesenchymal stromal cell (MSC) extracellular vesicles (EVs) to improve working memory, enhance white matter integrity and functional connectivity, facilitate clearance of Aβ42 protein, increase excitability of pyramidal neurons in monkeys and mitigate age- and Alzheimer’s (AD)-related neurodegenerative changes in human cortical organoids. These findings support the therapeutic efficacy of MSC-EVs in aging, however, recent evidence in the literature has demonstrated sex differences in the cargo of EVs. In this renewal, we now propose to conduct an in-depth analysis of the mechanistic action and therapeutic efficacy of EVs from MSCs from both male and female donors.